Shear Stress and Endothelial Pathophysiology in Intracranial Atherosclerosis

PROJECT SUMMARY/ABSTRACT
The overall goal of this proposal is to establish that the focal region of low shear stress (0-4 dyne/cm2)
immediately downstream or in the post-stenotic segment of ICAD is a marker of atherogenesis, providing a
therapeutic target for anti-inflammatory or anti-thrombotic interventions. Our central hypothesis is that post-
stenotic low shear stress associated with atherogenic endothelial pathophysiology provides a rational basis for
precision medicine of ICAD. Our preliminary data on low shear stress in these regions within SAMMPRIS
confirm the potential influential role of shear stress associated with endothelial pathophysiology recognized in
systemic atherosclerosis, yet extended to the cerebral circulation for the first time. Our three independent
specific aims leverage an ongoing, invaluable collaboration and the unmatched quality of the SAMMPRIS data
archive. The Neurovascular Imaging Research Core at UCLA will conduct the prospective experiments to
validate focal low shear stress measured on CTA CFD of MCA ICAD with detailed anatomical flow models
created from the same source images, with co-registered flow measured on 4D MRA [SA-1]. This step enables
us to use these validated flow models to directly observe flow vortices and adjacent low shear stress on particle
image velocimetry under microscopy [SA-1]. These validated MCA flow models serve as a scaffold for
endothelium, where the cell morphology, expression of VCAM-1 and platelet aggregation can be studied [SA-
2]. The clinical relevance of post-stenotic low shear stress (0-4 dyne/cm2) in these 50 MCA lesions will be
corroborated via comparison with CTA CFD of the contralateral homologous segment [SA-3]. Associations of
this clearly defined potential therapeutic target of post-stenotic low shear stress will be examined with respect
to other clinical variables and subsequent neurological outcomes in SAMMPRIS [SA-3]. These observations
will be similarly conducted across all 140 SAMMPRIS CTA CFD subjects to investigate the generalizability of
non-invasive CTA CFD in other arterial lesion sites [SA-3]. All image post-processing, CTA CFD, 4D MRA, 3D
printing and biological assays of endothelial pathophysiology will be conducted at UCLA, where we have
pioneered this workflow. The collaboration and guidance of the WASID and SAMMPRIS trial leadership is an
important element of this new approach to ICAD that employs the statistical expertise at Emory of these
landmark trials and their detailed imaging and clinical analyses. Our extensive preliminary work reflecting
collaborative expertise on a novel imaging and biological framework, coupled with intensive experience linking
the SAMMPRIS imaging and clinical datasets, provide a logical extension of knowledge on atherogenic low
shear stress into the cerebral circulation.

Public health relevance
PROJECT NARRATIVE/ RELEVANCE TO PUBLIC HEALTH STATEMENT This study on the role of Shear Stress and Endothelial Pathophysiology in Intracranial Atherosclerosis uses neuroimaging tests routinely performed in patients with symptomatic intracranial atherosclerosis to develop new insight on how mechanical forces on the vessel wall are associated with cellular changes that promote inflammation and clotting that may lead to stroke. These imaging and biological markers may create a new way to prevent such strokes, a leading cause of death and adult disability worldwide. These collaborative efforts that combine unique and established expertise are urgently needed to address the lack of proven invasive or noninvasive imaging tools or treatments for intracranial atherosclerosis and the unmet risk of recurrent stroke.